Pulmonary Valved Graft with Regeneration Potential for Pediatric Patients

Congenital heart diseases (CHD) refer to abnormalities present in the heart and the great vessels at birth.
CHD is the most commonly diagnosed birth defect and the leading cause of birth-related mortality. These
abnormalities can be a single defect or a combination of multiple defects that can alter the blood flow to and/or
from the heart to the body. CHD affects approximately 40,000 newborns annually in the US and 1.35 million
globally. The prevalence of CHD in the US population has been estimated to be close to 2.9 million patients,
which represents about 25% of the total number of CHD cases worldwide. Among patients with CHD, around
22% of the total critical CHDs are affected by anomalies that impact the right ventricular outflow tract (RVOT),
such as tetralogy of Fallot (ToF), pulmonary atresia, truncus arteriosus, and transposition of the great vessels.
Replacement valves and conduits are needed to replace structures that are congenitally absent or hypoplastic
in these conditions and restore normal blood flow.
The choice of materials for RVOT reconstruction in CHD patients remains a controversial and inadequate area
of study. Although glutaraldehyde-fixed bovine jugular vein (BJV) (Contegra) is a commonly used material due
to its unlimited availability and lack of antigenic reaction, complications such as stenosis at the distal
anastomosis of the conduit, aneurysm, or pseudoaneurysm have been reported in 6-50% of patients, with an
increased risk of infection after implantation. The glutaraldehyde crosslinking process results in a stiff and
calcification-prone tissue material, leading to early failure of the bioprosthetic device. Recent studies have
highlighted that the early failure of bioprosthetic valves may not only be attributed to calcification but also to
non-calcification mechanisms such as accumulation of advanced glycation end products (AGEs), altered
collagen microstructure, and elevated tissue crosslinking. Glutaraldehyde treatment also prevents cellular
repopulation of the tissues, making them incapable of cell-mediated remodeling and leading to the
accumulation of AGE-related products. Pediatric patients with a higher metabolism have a higher risk of
structural valve failure, which results in multiple re-operations throughout their lifetime. There is, therefore, an
urgent need to develop more durable pulmonary valved grafts that are resistant to calcification,
inflammation, thrombosis, and accumulation of AGEs, and that have regenerative potential, as a safe
reconstructive device for pediatric patients.
We propose to develop a pulmonary valved graft (PVG) from a decellularized and pentagalloyl glucose (PGG)
treated (Also referred to as TxGuardTM) bovine jugular vein. TxGuardTM PVG will be non-thrombogenic,
infection- and calcification-resistant, prevent accumulation of AGEs, and have a potential to remodel
and grow. Based on reproducible pre-clinical data during STTR Phase 1 and SBIR Phase II, we firmly believe
that the new device would provide an improved option for millions of patients than what is currently available.
Proposed specific aims for SBIR Phase IIB are: Aim 1: Design freeze of TxGuardTM PVG for final testing for
FDA submission. Sub-aim 1.1 - Optimizing and validating sterilization for TxGuardTM PVG. Sub-aim 1.2 -
Optimizing and validating packaging and storage for TxGuardTM PVG. Aim 2: Evaluate GMP grade TxGuardTM
PVG for material biocompatibility as per the ISO 10993 standards for permanent (>30 days) blood/ tissue
contact device. Aim 3: Test the final TxGuardTM PVG device for function in vitro and in vivo for FDA
submission. Sub-aim 3.1 - Hydrodynamic performance (steady flow pressure drop, steady backflow leakage,
pulsatile flow pressure drop, pulsatile flow regurgitation) for different conduit sizes and accelerated wear testing
(AWT) for three different sizes. Sub-aim 3.2 - Perform extended (140 days) GLP pre-clinical in-vivo testing
for TxGuardTM PVG (n=6) in growing lambs and compared to the clinically available Contegra BJV or
equivalent conduits (n=3). The outcome of these studies will be used for the FDA submission for the new
device approval following the Humanitarian Device Exemption (HDE) guidelines.
Confidential Page 1 of 1

Public health relevance
Congenital heart disease (CHD) is a condition that affects a significant number of newborns each year, with approximately 40,000 cases in the USA and 1.35 million globally. Valve and conduit replacements are required for repairing or replacing right ventricle outflow tract (RVOT) defects associated with CHD. This is necessary for defects such as absent pulmonary valve, aortic stenosis (Konno procedure, Ross procedure), double outlet right ventricle (Rastelli operation), extracardiac conduit, and pulmonary valve replacement (Tetralogy of Fallot). Unfortunately, the current replacement device materials are suboptimal and have a high failure rate, requiring reoperations in pediatric and adult patients. This research proposal aims to commercialize a breakthrough TxGuardTM pulmonary-valved graft (PVG) device that is designed to resist early degeneration and allow for regeneration with host cells, ensuring that the device grows with the pediatric patient. The proposed Phase IIB SBIR grant will help to de-risk several critical aspects of the research and complete pre-clinical test data required for FDA humanitarian device exemption (HDE) submission. Confidential Page 1 of 1